Multicenter Study of the Emergency Department Trigger Tool

Existing methods for surveillance of patient harm in the ED setting are inadequate, without any meaningful
change in decades. Trigger tools, popularized by the Institute for Healthcare Improvement’s Global Trigger
Tool, have been developed for multiple clinical areas and are used across the world, outperform traditional
approaches for surveillance of adverse events. These tools use a two-tiered review process where a nurse
screens records for triggers (predefined findings that make the presence of an AE more likely) and reviews
records with triggers for AEs, discarding those without triggers. We developed a consensus-based ED trigger
tool (EDTT) using a multicenter, transdisciplinary modified Delphi approach, subsequently pilot testing this in a
multicenter fashion with encouraging results. This was followed by a recently completed, AHRQ-funded single
center study to automate, refine and validate this tool. This study demonstrated that the EDTT is a high-yield
and efficient instrument for identifying adverse events in the ED. The present study will evaluate the refined,
automated EDTT), in a multicenter study. We will evaluate the EDTT’s generalizability and robustness at three
sites with large emergency departments, with a planned in-depth review of 9,000 ED admissions. We will use
natural language processing of electronic medical record narratives and machine learning to improve the EDTT
efficiency in trigger detection and AE discovery. We will establish the basis for a wider use and prepare for
scalability and usability of the tool, creating standardized, streamlined and free online training materials, and
by evaluating the tool in a real-world manner consistent with intended use.

Public health relevance
Project Narrative Commonly used approaches in Emergency Departments to detect adverse events are low yield and have not changed in decades, providing inadequate surveillance for patient harm. The need for improved methodology is critical, given the evolving role of the emergency department in the health care system. Trigger tools, developed for use in many healthcare settings across the world, detect all-cause harm, helping direct resources by identifying areas of risk and allowing an assessment of the effectiveness of quality improvement efforts over time. Trigger tools involve screening of records by a nurse for triggers (findings that make an adverse event more likely) and a review of only records with triggers searching for adverse events. Any events identified undergo confirmatory physician review. We developed a trigger tool for the ED, applying rigorous methods to identify predictive triggers, to computerize the screen for triggers eliminating manual review and improving record selection to enhance yield and efficiency. This tool demonstrates superior performance for detecting adverse events. We will now test this tool in a multicenter project to evaluate its broad application, confirming its utility and to continue to improve its yield and efficiency in adverse event detection by applying natural language processing and machine learning techniques.